Air Pollution-Derived Iron Exposure, Poverty-Related Stress, and Alzheimer's Disease Risk

A hallmark of Alzheimer’s Disease (AD) is regional brain “iron (Fe) overload”. We hypothesize that life-
long exposure to inhaled Fe via air pollution (AP) is a contributor to elevated brain Fe and AD risk. In support of
this hypothesis, AP has been linked to increased risk for AD with fine particulate matter (PM2.5) associated with
increased risk for dementia, reduced memory, processing speed and increased cognitive impairment, PM2.5
exposures include ultrafine particles and metal contaminants. Of the many redox active metals/trace element
pollutants in AP, Fe is often found at the highest concentrations. Studies examining Fe in frontal cortex of AD
brains reported an abundant presence of magnetite (Fe2+/Fe3+ iron oxide) nanoparticles, consistent with an
exogenous exposure rather than endogenous Fe source. It is critical to note that metal contaminants in AP are
not borne equally by everyone. Low socioeconomic status (SES) communities show the highest AP and metal
contamination levels (Fe - top percentiles ~0.135 µg/m3). In fact, neighborhood-level SES measures associate
with memory and dementia risk. Further support for differential risk and the need to investigate inhaled Fe toxicity comes from the subway systems where Fe levels range 1000 x higher, from 141±81 to 329±116 µg/m3. These
“ambient” and “subway” level concentrations provide the rationale for our experiments evaluating the link
between inhaled Fe and neurodegenerative risk. Our preliminary data in mice demonstrates that inhaled Fe at
“Subway” concentrations (~135 µg/m3) increases brain corpora amylacea, elevates phosphorylated tau protein
levels, and results in female-specific hippocampal reductions and memory deficits. (AIM 1). We will evaluate
whether AD-associated phenotypes arise at lower, closer to ambient Fe level exposures (1.35 µg/m3) and
evaluate a time course of prodromal progression seen in AD studies, while differentiating between exogenous
inhaled Fe from endogenous Fe. (AIM 2) Further escalating risk in these communities, poverty-related stress is
characterized by a largely uncontrollable set of conditions, comprising a major risk factor for cognitive decline.
Higher perceived stress is associated with increased risk for mild cognitive impairment, and two or more stressful
life events increases risk for all-cause dementia. We predict that “ambient” Fe and deprived environments with
uncontrollable stress exposures will result in AD neuropathology and memory loss, similar to higher “Subway”
exposures. (AIM 3) We additionally predict that, conversely, enrichment with controllable stress will improve
memory and ameliorate deficits associated with “Subway’ level Fe inhalation. These outcomes will derive from
shared biological effects on oxidative stress and ferroptosis, with consequently increased neuroinflammation,
reactive astrogliosis with white matter damage and neuronal loss. This research will inform public health policy
and prevention to improve quality of life by mitigating cognitive and memory loss. Moreover, these studies
advance our mechanistic understanding of how co-occurring environmental stressors, with shared biological
consequences, can converge to enhance risk.

Public health relevance
Two major risk factors for Alzheimer’s disease are elevated brain Fe levels and low socioeconomic status (SES) communities experiencing uncontrollable, poverty-associated stressors. Air pollution, and associated Fe contamination, are higher in low SES communities, subjecting these populations to two major risk factors for cognitive decline. The current grant proposes to evaluate the effects of inhaled Fe, at different concentrations and in stress vs. resilience-inducing contexts, to advance our mechanistic understanding of how co-occurring environmental stressors, with shared biological consequences, can converge to enhance or mitigate risk for memory loss and Alzheimer’s Disease.